Rare Disease Clinical Research Training Program

The goal of the R25 Rare Disease Research (RDR) curriculum is to prepare a multidisciplinary group of rare disease (RD) clinical researchers to perform studies in both genetic and non-genetic rare disorders. This will be accomplished using a one-year 80-hour blended teaching model. An objective of this program is to create online modules, podcast-style lectures, recorded didactic-style lectures, and in-person experiences that enable learners from different health care disciplines and medical specialty backgrounds to actively participate in the curriculum. The curriculum focuses on subjects including RD-specific study design, unique analysis approaches, multi-center recruitment methods, and small cohort design. The field of RDR recognizes that collaborative research and team science are critical to improving therapeutic opportunities and clinical outcomes of the rare disease community. This concept serves as the unifying theme of the curriculum. We also highlight how researchers can fund their work through philanthropy, innovation, entrepreneurship, as well as traditional funding sources. By changing how the next generation of clinical researchers approach study design, recruitment, and funding, we expect to advance health among the approximately 30 million Americans who are estimated to have a rare disease.

Public health relevance
Project Narrative As the number of rare disorders grow each year, the need for new treatments, approaches, and understanding continues to expand. This program has a five-year track record of successfully increasing early career clinical researcher’s intent to remain in research. By continuing the successful program, expanding to a broader group of clinical researchers, and creating an alumni longitudinal component, this program will continue to support the clinical research pipeline.